Dynamic bidirectional sensorimotor interactions in stuttering

PROJECT SUMMARY/ABSTRACT
Understanding the basic neural mechanisms underlying stuttering is widely acknowledged as fundamental to
informed diagnosis and treatment. The required cornerstone for this important knowledge is a theoretical
framework of stuttering that accounts for various primary and associated speech characteristics, and that is
consistent with empirically-verified models of sensorimotor control and neural functioning. The research
program proposed here takes a comprehensive neurobiological approach to developing a mechanistic model
of stuttered speech dysfluencies through an integrated series of theoretically-motivated, hypothesis-driven,
state-of-the art experiments. A common theme throughout the proposed experiments is the fact that the neural
control of movement depends on dynamically adjusted bidirectional interactions between efferent and afferent
systems. The direct aim is to elucidate these sensorimotor interactions and their role in stuttered speech.
Based on empirical and computational work suggesting that the CNS is able to control fast voluntary
movements by continually predicting future sensory states, our lab recently found in multiple studies that
typical speakers modulate auditory processing mechanisms prior to the initiation of speech movements, but
that this mechanism is entirely lacking in adults who stutter. Thus, predictive modulatory mechanisms prove to
be a particularly powerful model for elucidating the mechanisms underlying speech motor breakdowns in
stuttering. The individual experiments within this program of research are designed to determine whether
stuttering individuals’ well-documented deficit in pre-speech auditory modulation is already present in
childhood close to stuttering onset, whether this deficit is specific to motor-to-auditory interactions or also
affects processing in the somatosensory domain, and to uncover various aspects of the phenomenon’s
functional relevance in speech sensorimotor control. The proposed studies comparing both children and adults
who stutter with typically fluent speakers have the potential to offer mechanistic insights into the development
and limitations of the speech sensorimotor system in this common disorder of speech fluency. Specifically,
crucial new insights will be gained into the involvement of sensorimotor interactions in feedback monitoring
mechanisms that have long been hypothesized to play a fundamental role in the physiological basis of
stuttering. Moreover, these findings will offer suggestions for novel treatment approaches such as non-invasive
brain stimulation of neural pathways involved in pre-movement motor-to-sensory signaling. Thus, this work's
direct relevance to public health lies in its contributions to understanding the neural mechanisms underlying
stuttering and – by generating such new insights – facilitating the development of improved approaches to
diagnosis and treatment.

Public health relevance
PROJECT NARRATIVE These integrated brain and behavior studies will contribute to a better understanding of the neural systems and processes involved in stuttering, a communication disorder that affects 3.5 million Americans. Specifically, this series of experiments will investigate if stuttering speakers’ speech motor planning systems fail to appropriately prepare the sensory systems that monitor auditory and movement feedback once speech movements are initiated. Findings will not only suggest new research directions but also facilitate the development of novel approaches to the diagnosis and treatment of stuttering.